SELECTIVE INHIBITORS OF STEROID TRANSFORMING ENZYMES

The objectives of this proposal are the synthesis and evaluation of novel selective inhibitors of steroid-transforming enzymes. Some of these steroid analogs are designed as active site-directed irreversible inhibitors of 3Beta- and (3 and 17)Beta-hydroxysteroid dehydrogenases and others are designed as inhibitors of 17Beta-hydroxysteroid dehydrogenases as well as processes involved in the oxidative degradation of lanosterol and of cholesterol. Others are intended to be reversible inhibitors of these enzymes. The mechanisms by which enzyme inhibition occurs will be studied. These inhibitors may be of value not only in studies of enzyme action but as potential therapeutic agents in hormone-dependent diseases and in hypercholesterolemic states.